PHASE I STUDY OF TEMOZOLOMIDE IN TREATMENT OF ANAPLASTIC ASTROCYTOMA

Temozolomide will be evaluated for safety, efficacy, maximum tolerated dose and pharmacokinetics in patients with Anaplastic Astrocytoma experiencing first relapse. Temozolomide will be administered orally 1/day x 5 days every 28 days. Pts will fast 4 hrs before & 2 hrs after each dose. Pharmacokinetics will be drawn on Day 1 Cycle 1. All patients will be drawn at baseline (before dosing) and 4 times post-dosing.